Genetic, molecular, and neural mechanisms of alcohol-induced effects on sleep

–––– Project Summary/Abstract –––––––––––––––––––––––––––––––––––––––––––––––––––––––––––
Alcohol use and abuse affect millions of people, exacting immense tolls on personal and public health and the
economy. One of the most reported consequences of active alcohol use and recovery from alcohol use disorder
is insomnia, which includes difficulties falling asleep (increased sleep latency), staying asleep, or achieving high-
quality sleep. Alcohol-induced insomnia is highly predictive of relapse, making it an important driver of persistent
alcohol abuse. For improved treatment of alcohol use disorder and prevention of relapse, we need to understand
the mechanisms of alcohol-associated sleep problems, which are currently unknown. Drosophila offer a valuable
approach to unraveling these mechanisms thanks to their translational relevance for sleep and alcohol responses
and their high economy of scale. My preliminary data show that a single, high-dose alcohol exposure robustly
increases sleep latency, the time it takes to fall asleep, for at least six nights. Based on these findings, in Aim 1,
I propose determining the genetic contributions to alcohol-induced sleep delays. I will do so by examining human
genes, identified with Genome-Wide Association Studies, that are linked to alcohol and sleep phenotypes. I will
test these candidate genes in the Drosophila nervous system, examining their necessity for alcohol-induced
sleep effects. In Aim 2, I will determine the roles of neurons and conserved neurotransmitter systems in alcohol-
induced sleep disruptions. I will utilize a subset of a few hundred uncharacterized neurons that our lab has found
to affect both sleep latency and alcohol responses. I will examine the role of these in alcohol-induced sleep
delays and determine the neurotransmitters required for regulating sleep, alcohol responses, and their interaction
in these neurons. Together, these experiments will identify potential genetic and molecular targets for treating
alcohol use disorders and their associated sleep disturbances. While I have a strong academic background and
laboratory experience focused on rodent addiction, I require additional training to develop as an independent
researcher. My goals as a graduate student are to build strength in neurogenetics, Drosophila model systems,
the neurobiological mechanisms of alcohol abuse, behavioral analysis, and tools for studying these topics. This
foundation will prepare me to pursue my long-term career goal of obtaining a tenured faculty position. I anticipate
that my preliminary data plus the aims described here will produce at least one scientific manuscript each while
also supplying preliminary data for future grant applications. Under the training provided by this fellowship, I will
refine technical skills, deepen my expertise in alcohol research, and become independent in experimental choice,
design, analysis, and communication. These skills will propel me on my trajectory towards a career as an
independent researcher and educator. While facilitating these goals, the proposed project will also shed
necessary first mechanistic light on the phenomenon of alcohol-induced sleep loss, which is a critical contributor
to persistent human alcohol use.

Public health relevance
–––– Project Narrative ––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––– Disrupted sleep is one of the most universally reported outcomes of active alcohol use and recovery from alcohol use disorder, and the harmful influence of alcohol on sleep is well-characterized but remains difficult to treat. To develop better therapies for alcohol-induced sleep effects, we must understand the genetic and molecular mechanisms underpinning the relationship between alcohol use and poor sleep. Utilizing Drosophila’s behavioral similarities with humans, many genetic tools, and high economy of scale, this work will identify genes and neural circuits regulating alcohol-induced sleep disturbances, thereby offering mechanistic targets for treating these disruptions.